Targeted EHR-based Communication of Diagnostic Uncertainty (TECU) in the ED: An Effectiveness Implementation Trial

PROJECT SUMMARY
At least 37% of patients treated in the emergency department (ED) are discharged without a definitive
diagnosis, thus leaving the encounter with diagnostic uncertainty. Transitions of care are high-risk periods for
patient safety, especially when patients are discharged with diagnostic uncertainty, and thus are still within the
diagnostic process. Effective communication between clinicians and patients is essential to improve the quality
of these care transitions. In prior AHRQ-funded research, we developed several tools to support high quality
discharge in the setting of diagnostic uncertainty, including a communication checklist, a training program for
physicians in uncertainty communication, and a patient-facing 1-page information sheet about being
discharged with uncertainty. We now propose to leverage the electronic health record (EHR) to implement a
multifaceted strategy to facilitate higher quality discharge transitions for patients discharged from the ED with
diagnostic uncertainty. Our Targeted EHR-based Communication about Uncertainty (TECU) strategy will be
activated every time an ED clinician enters an uncertain diagnosis for a patient being discharged, and will
notify the clinician to counsel the patient about uncertainty while additionally triggering automated 1) insertion
and printing of the patient handout, 2) printing of the clinician-facing checklist to guide the discharge
conversation, and 3) sending of an inbox message to the primary care provider (PCP). We will conduct a pre-
post pilot trial with a hybrid type 1 effectiveness implementation design with the goals of: 1) Testing the
preliminary effectiveness of TECU compared to standard of care in reducing patient uncertainty and return ED
visits and 2) Evaluating the adoption of TECU and exploring patient and clinician barriers and facilitators to
TECU implementation. This work will be led by experienced researchers with expertise in health services
research, clinical trials in emergency medicine, patient communication, health literacy, diagnostic uncertainty,
informatics, and implementation science. The TECU strategy will be easily disseminated as it will be built in
Epic, the world’s leading EHR vendor, and will be available for health systems to implement through the Epic
Community Library. This project has potential to significantly impact the quality and safety of care transitions
for the one-third of patients leaving the emergency department with diagnostic uncertainty.

Public health relevance
PROJECT NARRATIVE Over one third of patients treated in the emergency department (ED) are discharged without a definitive diagnosis, leaving patients with unaddressed fear regarding their symptoms and minimal assistance in their transition home from the ED. We developed tools to address uncertainty at the time of ED discharge in prior research and we now propose to leverage the electronic health record to implement a multifaceted strategy to facilitate higher quality discharge transitions for patients discharged from the ED with diagnostic uncertainty. Data on efficacy and implementation resulting from this trial will inform refinement of our implementation strategy as we work to disseminate the strategy widely with the goal of improving quality of care transitions for the one third of patients discharged from the ED with diagnostic uncertainty.